Development of next-generation biologics programmed with multifunctional synthetic chemistries

PROJECT SUMMARY
Protein biologics constitute an important class of therapeutics owing to their high specificity, bioactivity and
potential for tunability. Cytokine (CK) proteins applied as biotherapeutics show great promise for several disease
indications, including cancer, multiple sclerosis, and hepatitis C infection. However, major barriers preventing
the advancement and widespread clinical use of CKs to address critical public health needs include: (I)
tendencies to cause systemic immune activation as a result of their on-target, off-tumor effects (ii) rapid
proteolytic degradation and clearance by the kidneys as small proteins (<20 KDa) with short half-lives in
circulation and (iii) frequent and high dosing leading to undesirable “peak-and-valley” pharmacokinetic (PK)
profile which result in (iv) reduced therapeutic efficacy, dose-limiting toxicities and reduce patient compliance.
New strategies are urgently needed for simultaneously targeting tumor antigens to build specificity and
localization while also tuning half-life. A multi-functionalized CK with tunable properties could lead to the next
generation of clinical biologics. Existing approaches to extend half-life such as the attachment of polyethylene
glycol moieties (PEG), tend to elicit undesired immunogenicity and new tools are required solve this defining
challenge. Pearl Bio’s proprietary synthetic biology platform technology is built on three core technologies:
Genomically Recoded Organisms (GROs), engineered orthogonal translation systems (OTS), and tethered
ribosomes for production of novel proteins incorporating synthetic amino acids (sAAs) including novel sAAs
previously inaccessible for precise functionalization. In proposed studies, we will leverage this platform to
demonstrate the tunability of CK half-life as well as tumor-targeting through precise and multi-site incorporation
and functionalization of sAAs with fatty acid groups. Specifically, we will (1) Demonstrate multisite incorporation
of sAAs into IL-15, (2a) Perform efficient lipidation and purification of synthetic IL-15 biologics with fatty acid for
tuning half-life, (2b) Enable tumor-targeting functionalization using engineered antibody/nanobody (multiple
instances if desired) and (3) Measure immunogenicity, bioactivity and albumin/tumor-antigen binding of these
IL-15 variants in vitro. In summary, during Phase 1 we will develop multi-site fatty acid functionalization of
cytokines and perform in vitro testing for bioactivity and immunogenicity. In Phase 2 studies, albumin and tumor
targeting capabilities would be combined to create a multi-functionalized CK with tunable half-life and tumor
specificity. Phase 2 in vivo studies will be used to test half-life tuning, tumor homing and efficacy of the multi-
functionalized CKs for further therapeutic development. We envision that this project could establish the basis
for entirely novel and programmable protein biologics with utility across a broad range of disease indications.

Public health relevance
PROJECT NARRATIVE Despite their potential, protein biologics, and in particular, cytokines, often exhibit poor “peak-and-valley” pharmacokinetic profiles, rapid degradation, systemic immune activation (due to their on-target, off-tumor effect), resulting in dose-limiting toxicities, impaired efficacy and poor patient compliance. To address these defining challenges, and advance biotherapeutic development beyond the state-of-the-art, Pearl Bio has developed a proprietary technology platform to enable precise, multi-site functionalization of next-generation biologics to catalyze new protein drug design capabilities. In this project we will generate a set of functionalized IL-15 therapeutic candidates that are (a) lipidated to tune half-life and (b) endowed with novel tumor targeting modalities for enhanced binding specificity.